2/2: An Anesthesia-Centered Bundle to Reduce Postoperative Pulmonary Complications: The PRIME-AIR Study.

PROJECT SUMMARY
Postoperative pulmonary complications (PPCs) are conditions affecting the respiratory tract that adversely
influence the clinical course of patients after surgery. PPCs are a major perioperative entity influencing the
morbidity and mortality of a large number of patients, and with substantial impact on health care costs. National
estimates suggest 1,062,000 PPCs/year, with 46,200 deaths, and 4.8 million additional days of hospitalization.
Abdominal surgery is the field with the largest absolute number of PPCs. Although PPCs are as significant and
lethal as cardiac complications, research in this area has received much less attention, and well established
perioperative strategies to minimize PPCs are regrettably limited. Recently, our and other groups have
suggested a crucial role of anesthesia related interventions such as ventilatory strategies, and administration
and reversal of neuromuscular blocking agents in reducing PPCs, findings that are consistent with the
beneficial effects of lung protective ventilation during the adult respiratory distress syndrome (ARDS). Surgical
patients differ substantially from ARDS patients as most have no or limited lung injury at the start of surgery.
Yet, intraoperative anesthetic and abdominal surgery interventions result in lung derecruitment and can
predispose to or produce direct and indirect lung injury. Thus, effective anesthetic strategies specifically aiming
at early lung protection are greatly needed. Yet, there is substantial lack of data on strategies to avert PPCs,
leading to the current unsatisfactory anesthetic practice on PPC prevention. Based on our previous findings,
we propose an anesthesia-centered bundle to optimize perioperative lung recruitment and reduce PPCs. It
consists of optimal mechanical ventilation comprising individualized positive end-expiratory pressure (PEEP) to
maximize respiratory system compliance and minimize driving pressures; individualized use of neuromuscular
blocking agents and their reversal; and postoperative lung expansion and early mobilization. We propose to
conduct a prospective multicenter randomized controlled pragmatic trial with blinded assessor to compare
PPCs in 750 patients undergoing major open abdominal surgery receiving an optimal individualized anesthetic-
centered management bundle composed of those interventions versus usual care. We hypothesize that this
anesthesia-centered bundle, focused on perioperative pulmonary recruitment, will minimize multiple and
synergistic factors responsible for the perioperative pulmonary dysfunction and reduce the rate of PPCs. To
test this hypothesis, we will compare the participant's PPC severity using a previously published 5-point scale
based on the most serious PPC during the first seven days after surgery between intervention groups. As the
statistical and data coordinating center for the study we will: ensure rigorous study design; meticulous
implementation of the study in collaboration with the clinical coordinating center; and perform comprehensive
data analysis. Our plan for widespread dissemination of results will change clinical practice by establishing a
new, clinically feasible anesthesia-centered strategy to reduce PPCs after open abdominal surgery.

Public health relevance
Project Narrative Postoperative pulmonary complications (PPCs) are a major cause of illness and death for patients undergoing open abdominal surgery. The PRIME-AIR study will test whether an intervention bundle (including individualized ventilator settings during anesthesia, optimized muscle relaxation and reversal, and monitoring incentive spirometry after surgery) will reduce the occurrence and severity of PPCs. The Statistics and Data Coordinating Center will provide the methodological and logistical support for the design, data collection, quality control, and analysis of data generated from the PRIME-AIR study.